Core C: Transgenic/Knockout Core

Core C is central to the mission of the PPG since it will provide critical tools to PPG
investigators for analyses of coinhibitory and costimulatory molecules to develop an
understanding of the functions of positive and negative second signals in regulating T cell
activation, tolerance and exhaustion. This Core will provide PPG investigators with an important
and unique collection of mouse strains that enable studies of the in vivo functions of T cell
costimulatory/coinhibitory molecules individually, and their interplay. Core C has the expertise
with both conventional and conditional transgenic and knockout technology, as well as
CRISPR/Cas9 engineering, which will enable the generation of novel mouse strains for
analyzing the functions of immunoregulatory molecules in vivo. Our specific aims are: 1) To
generate novel knockout and transgenic mouse strains, conditionally or inducibly, 2) To
generate mouse strains that facilitate analyses of the functions of coinhibitory/costimulatory
molecules by breeding knockout mice with TCR transgenic or reporter mice, or analyses of
interactions between coinhibitory receptors or interplay between positive and negative second
signals 3) To maintain and provide mice of existing transgenic and knockout strains to PPG
investigators. Core C will work closely with project investigators in all 3 projects, not only to
provide them with transgenic and knockout strains, but also to generate novel strains based
upon their findings in PPG projects. Core C also will provide knockout mice to Core B for
immunization to generate novel mAbs. Taken together, these activities of Core C will provide
PPG investigators with novel mouse strains for studying the roles of costimulatory and
coinhibitory in controlling T cell responses in mouse models of infection, autoimmunity, cancer
and chronic graft-versus-host disease.

Public health relevance
Narrative Core C will make genetically engineered mouse strains for use by Program investigators in experimental models of infection, autoimmunity, cancer and transplantation. These mouse strains will be useful tools for identifying mechanisms that regulate immune responses, and guiding translation to new therapies for human diseases. .